Understanding the effect of Hao-Fountain syndrome-causing mutations on neuronal development

ABSTRACT
Hao-Fountain syndrome is a newly identified rare pediatric neurodevelopmental disorder caused by deletions
and mutations of the USP7 gene. The molecular mechanisms and pathophysiology of the disease remain poorly
understood, preventing the development of potential treatments for Hao-Fountain patients. USP7 is a
deubiquitinating enzyme implicated in the maintenance of protein homeostasis, stem cell identity, self-renewal,
and control of dendritic branching in primary neurons. A model system has not yet been created but is
indispensable for understanding the disease and for the evaluation of potential personalized therapies for Hao-
Fountain Syndrome. In this proposal, we will create the first human-based cellular model of Hao-Fountain to test
the effect of disease-linked mutations on the enzymatic function of USP7 (Aim 1), and on neuron differentiation
potential and morphology (Aim 2). The patient-derived induced pluripotent stem cells will be differentiated into
cortical neurons to create the Hao-Fountain model system that will be shared with the greater community to
accelerate the understanding of this newly discovered and devastating disease.

Public health relevance
NARRATIVE Hao-Fountain syndrome is a newly identified rare pediatric neurodevelopmental disorder caused by deletions and mutations of the USP7 gene. The patients suffer from global developmental delays, behavioral abnormalities, autism, and variably impaired intellectual development with speech delay. There is currently no cure for this disorder which places a significant burden on both children and parents; therefore, we propose to develop and validate a new human-based model of the Hao-Fountain syndrome that is essential for understanding the molecular mechanisms of the disease, and the discovery of potential treatments for it in the future.